Community Engagement Core

Modified Project Summary/Abstract Section
Longstanding differences in health outcomes across communities are the result of a complex interconnected set of social, environmental, and health-system factors. Improving these outcomes requires meaningful partnerships across stakeholders that operate from community-based and community engagement principles. North Carolina Central University’s (NCCU) RCMI Center for Health Disparities Research (RCHDR) includes a Community Engagement Core (CEC) with a goal of strengthening community engagement and building strong partnerships with community stakeholders in all communities of North Carolina. During initial funding we were able to establish the CEC as a community-centered and trusted source with several key focus areas. In addition to our community facing efforts and activities, part of the community capacity building focused on researchers where we convened a group committed to thoughtful and ethical research, as seen in our ‘Research with Care’ brand, of ‘TEAM NCCU’. In this competitive renewal, through innovative community engagement efforts, the NCCU-CEC will continue to build and support community capacity, establish relationships with community-based organizations, and public health departments, be responsive to health needs, promote health outcomes research, increase research participation, and disseminate findings from RCHDR research projects.

Public health relevance
Modified Public Health Relevance Section Persistent gaps in access to quality care among U.S. communities contribute to worsening health outcomes and remain a critical public health challenge. The role of HBCUs in addressing and being represented in the community has proven to be essential to address health challenges through research and community engagement. Through this competitive renewal, NCCU's RCMI Center for Health Disparities Research (RCHDR) will continue enhancing NCCU's research ecosystem to develop successful scientists conducting impactful and cutting-edge research that aim to improve health outcomes for all populations.